Use of Vibrational Reporters to Measure Dynamics and Distances in RNA and Proteins

PROJECT SUMMARY
The long-term objective of this research is to use vibrational reporters and infrared (IR)
spectroscopy to study protein and nucleic acid structure and dynamics. A full understanding of these
requires a sensitive, site-specific, and relatively non-invasive methodology with sufficient spatial and
temporal resolution. Nitrile (CN) and azide (N3) vibrational reporters satisfy these requirements when
coupled with IR spectroscopy.
The vibrational reporter unnatural amino acid (UAA) 4-cyano-L-phenylalanine (CNPhe) will
be site-specifically genetically incorporated, individually into numerous sites in adenylate kinase (AK).
The local environments of the nitrile group of CNPhe will then be assessed upon thermal unfolding of
the protein with temperature-dependent linear IR spectroscopy. The molecular interpretation of these
spectroscopic results will be aided by X-ray crystallography in collaboration with Christine Phillips-
Piro (F&M). The aggregation mechanism and kinetics of AK will also be explored with CNPhe and IR
spectroscopy.
The ability to potentially enhance the effectiveness of the nitrile reporter of CNPhe and 5-
cyano-2'-deoxyuridine (CNdU) will be explored by correlating the temperature-dependent nitrile
symmetric stretch frequency with either the temperature-dependent 13C or 15N NMR chemical shifts
of isotopically labeled variants of these molecules. The goal will be to gain a better understanding of
the hydration and electrostatic effects impacting the nitrile symmetric stretching frequency. This
method will then be extended to superfolder green fluorescent protein (sfGFP).
The further development of a method to extract the geometric orientation between two
vibrational reporters using 2D IR spectroscopy in biomolecules will also be pursued. In collaboration
with Matthew Tucker (University of Nevada, Reno), the anharmonic coupling between the vibrational
reporter pairs, measured by 2D IR spectroscopy, will be correlated to the distance and angle between
these reporters in several systems including: a nucleoside based hydrogen-bonded dimer system, a
RNA tetraloop hairpin (prepared in collaboration with Ronald Micura, University of Innsbruck,
Austria), sfGFP, and adenylate kinase (AK) constructs, where each system contains either two nitrile
reporters or one nitrile and one azide reporter.
Franklin & Marshall College undergraduate students will play an integral role in this
biomedical health-related research.

Public health relevance
PROJECT NARRATIVE The proposed research focuses on using infrared (IR) spectroscopy with vibrational reporters (nitriles and azides) to probe local structure and dynamics in two proteins (adenylate kinase [AK] and superfolder green fluorescent protein) and in RNA hairpins. Mutations in AK are associated with hemolytic anemia, reticular dysgenesis, and ciliary dyskinesia. RNA structure is complex and the information gained from this research has the potential to benefit future advances in RNA vaccines, CRISPR, and RNA interference therapies.